Mobile phone-based screening for anemia in young children in western Kenya

PROJECT SUMMARY/ABSTRACT
Anemia is a common, serious, and neglected global public health problem, affecting over 2 billion people with
especially high prevalence among children in low-and middle-income countries (LMICs). Unfortunately, despite
the high prevalence and negative health consequences of anemia, few routine screening programs exist in
LMICs. There is a critical need to identify an easy-to-implement, low-cost strategy to screen and treat anemia
and its causes in LMICs, where > 50% of the population and as many as 75% of children under-5 years of age
suffer from anemia. In many LMICs, anemia goes undiagnosed, primarily due to lack of access to accurate and
affordable laboratory diagnostics. The most common global causes of anemia (iron deficiency, malaria, sickle
cell disease) are relatively easy to diagnose with highly effective treatments. Children with chronic illnesses such
as HIV are at an even higher risk of anemia with a significant impact on health outcomes. In most high-income
countries, infants are universally screened at birth for sickle cell disease and are routinely screened for anemia
at least once in early childhood. This screening and treatment paradigm is highly effective and averts the
significant morbidity and early mortality associated with anemia. In LMICs, although >50% of children are anemic,
there is no systematic screening and limited capacity to diagnose sickle cell disease, iron deficiency, or other
underlying causes of anemia when it is detected. The lack of diagnostic laboratory capacity to measure
hemoglobin concentration accurately and affordably is a primary limitation to the systematic identification of
anemia. In this study, we will use a smartphone-based, noninvasive method to measure hemoglobin and detect
anemia by analyzing photos of the palpebral conjunctiva. This smartphone-based method has been shown to
accurately measure hemoglobin in a controlled setting in the US but has not been rigorously evaluated in settings
where more severe anemia is common. In this study, we will evaluate the utility and accuracy of this mobile
health (mHealth) tool to diagnose anemia among young children in western Kenya. Through the R21 phase, we
will (Aim 1) develop a community advisory board to proactively consider acceptability and feasibility of this
screening intervention and develop an implementation plan and (Aim 2) evaluate the diagnostic accuracy of this
mHealth tool in detecting anemia among Kenyan children who are HIV-exposed and unexposed, within the
context of multiple etiologies of anemia. If found to be valid, use of this anemia screening tool will be integrated
into the health system, according to the implementation plan developed by the Community Advisory Board. We
will measure implementation outcomes of the screening program and prospectively evaluate a disease-specific
follow-up and treatment plan to assess the clinical impact of this mHealth-based anemia screening and treatment
program for children living in western Kenya. This research has important implications to demonstrate the
feasibility of an mHealth anemia screening tool and will address a critical gap towards addressing the neglected
global burden of anemia.

Public health relevance
PROJECT NARRATIVE Anemia is an important and largely unaddressed global public health problem, affecting up to one third of the world’s population (>2 billion people), most commonly children living in low- and middle-income countries, where access to affordable and accurate diagnostics are limited. Most cases of anemia are caused by treatable conditions such as iron deficiency, malaria, or sickle cell disease. In this study, we will evaluate the feasibility and accuracy of a novel and non-invasive diagnostic tool to measure hemoglobin concentration and diagnosis anemia using smartphone photos of the conjunctiva in a high-risk population of children living in western Kenya with the concurrent development of a community-engaged implementation plan for larger scale anemia screening using this mHealth tool.